Targeted delivery of a VEGF‐blocking scFv by CD70 CAR‐T cells to enhance anti‐tumor activity in renal cell carcinoma

PROJECT SUMMARY
Although chimeric antigen receptor (CAR)-T cells drive dramatic and durable remissions in patients with B-cell
malignancies, responses in solid tumors have been more challenging. There is a dearth of highly effective
“armoring” strategies for CAR-T cells to generate additional proteins that augment CAR-T cell function and
modulate the tumor microenvironment (TME). Our long-term goal is to develop safe and effective CAR-T cell
therapies for solid tumors. The overall objective is to determine the effect of locally secreted VEGF blockade
on CD70 CAR-T cell function, safety, and anti-tumor efficacy in renal cell carcinoma (RCC). Our central
hypothesis is that locally secreted VEGF blockade will prevent CAR-T cell exhaustion while blocking
angiogenesis/tumor growth, and pathologic endothelial activation. The underlying rationale is that
determination of the preclinical therapeutic efficacy and associated mechanisms of locally secreted VEGF-
blockade will offer a strong scientific framework for new strategies to cancer therapy. To attain the overall
objective, we will pursue two specific aims: (1) Determine the effect of secreted VEGF blockade on CD70-
CAR-T cell biology ; and (2) Define the capacity for CD70-CAR-T cells with secreted VEGF blockade to
modulate RCC tumor proliferation, angiogenesis, and endothelial activation in vivo. Approaching the project,
the candidate will examine each side of the immune synapse, in turn, by (1) defining the effects of anti-VEGF
single chain variable fragment (scFv) secretion on CAR-T cells through the underlying CD70 CAR-T biology
and honing in on the site of actions of the VEGF-scFv (paracrine, autocrine, or intracrine) (Aim 1), and (2)
determining the effects of anti-VEGF scFv secretion on RCC tumor cells, angiogenesis, and endothelial
activation via in vivo orthotopic RCC tumor models, cytokine release syndrome models, and VEGF-blockade
cardiovascular toxicity models (Aim 2) The applicant, Dr. Mark Leick, an oncologist at the Massachusetts
General Hospital (MGH) spends 80% of his time in translational research and 20% in clinical practice caring for
patients with cancer. He has outlined a five-year career development plan consisting of coursework,
conferences, seminars, and structured mentoring in experimental design, mouse modeling, angiogenesis and
VEGF signaling pathways, CAR-T signaling, and renal cell carcinoma to acquire the necessary skills required
to perform his research and to reach his goal of becoming an independent investigator in translational
research. His research is directly relevant to the mission of the NCI to conduct cancer research to advance
scientific knowledge and help all people live longer healthier lives using immune cell therapies. Supervising Dr.
Leick’s mentorship and training is Dr. Marcela Maus, a worldwide leader in cellular immunotherapy. Dr. Leick
will conduct this research at MGH and leverage the exceptional research and teaching environments of his
scientific advisory committee (MGH, Dana Farber Cancer Institute, Beth Israel Deaconess Medical Center, and
Boston Children’s Hospital).

Public health relevance
PROJECT NARRATIVE Decades of research have led to the development of VEGF targeted agents for solid tumors; however, the true potenƟal of these agents is limited by systemic toxicity. VEGF also mediates T‐cell dysfuncƟonal cellular programs. This research project aims to both improve T‐cell ﬁtness and anƟ‐tumor acƟvity through CD70 targeted CAR‐T delivery of a VEGF‐blocking single chain variable fragment for renal cell carcinoma.